STNFR551GG AND METHOTREXATE IN TREATING PATIENTS WITH ARTHRITIS

Determine whether study drug or its combination with methotrexate improves the clinical and functional manifestations of rheumatoid arthritis after 12 weeks of treatment and that the study drug has a favorable efficacy/tolerance ratio.